Carle Cancer Center NCI Community Oncology Research Program (NCORP)

Carle Cancer Center in Urbana, Illinois, a current NCI Community Oncology Research Program (NCORP), is applying for renewed funding to continue its commitment to provide cancer prevention, control, screening, and care delivery research in the community setting. Joining in our efforts are affiliate institutions, Rush-Copley Medical Center in Aurora, Illinois and St. Vincent Anderson in Anderson, Indiana. Together, the NCORP affiliate institutions’ objectives are to engage institutions and communities in the participation of research to advance all aspects of cancer care. The goal is to optimize the personal and institutional advances in health care through research that becomes readily transferable across other health care systems and populations for the benefit of all. The Carle NCORP is devoted to engage all members and communities to be represented in clinical and translational research. Over the next six years, the Carle NCORP will continue to recruit, train, and mentor any population or health system in the region to similarly participate in clinical research. Carle's strength is its highly integrated health care system, from top to bottom (organizationally and electronically), comprised of 928 primary care and specialty providers, all invested in a research culture. The Carle NCORP’s three main strengths are cancer control, prevention, and care delivery research, novel imaging, and capabilities to acquire bio-specimens. Attributes in place to ensure a successful NCORP include:
Over 35 years of community research oncology experience
Multi-disciplinary and multi-institutional integration
Significant representative population in eastern Illinois and portions of Indiana
High accrual particularly with cancer control, prevention, and care delivery trials
Cross discipline research initiatives at Carle Foundation Hospital, Rush Copley, and St. Vincent Anderson
Stephens Family Clinical Research Institute infrastructure and support
Institutional support for the research program as a whole
Affiliation with academic centers
Initiatives for imaging, bio-specimen, electronic data mining
High quality data
Strong regulatory processes

Public health relevance
The Carle Cancer Center NCORP provides access to National Cancer Institute (NCI) clinical trials to the residents of eastern Illinois and portions of Indiana. Expanding clinical research opportunities beyond the academic centers and into individual communities provides a broadly applicable evidence base that contributes to improved patient outcomes.